Defining the Function of Age-Related Epimutation in Intestinal Tumorigenesis

PROJECT SUMMARY
The accumulation of aberrant DNA methylation is a shared molecular phenomenon in both biological aging and
cancer development. Indeed, epimutation — mitotically stable gene silencing associated with epigenetic
alterations in DNA methylation — is now recognized as a common feature of human cancer. However, our
understanding of how age-related epigenetic changes contribute to tumor progression and response to therapy
is surprisingly limited. The proposed research builds upon our previous work revealing aberrant promoter DNA
methylation in both human and mouse colons. Notably, we identified age-dependent epimutation of the tumor
suppressor p16 as a driver in the adenoma-adenocarcinoma sequence of intestinal tumorigenesis. We also
identified two additional candidate tumor suppressor epimutations that likely contribute to colorectal cancer
(CRC). We hypothesize that age-related epimutations allow for subsequent accumulation of both genetic and
epigenetic alterations that promote CRC development and progression. We will test this hypothesis by 1)
Employing epigenetic engineering in mice to model advanced human colon cancers; 2) Investigating the
functional implications of combined epimutations in intestinal stem cells; and 3) Testing combinatorial epigenetic
immunotherapy in mouse colon tumors carrying a driver epimutation. We will elucidate the epigenetic
mechanisms driving metastasis in CRCs with BRAF mutations. Our preclinical studies will provide key insights
into optimally integrating epigenetic therapy into clinical trials. Leveraging organoids and CRISPR epigenome
editing will allow us to test new, uncharacterized epigenetic drivers that regulate intestinal stem cell function and
promote tumorigenesis. These studies will establish more faithful mouse models of human CRC development,
advancing our understanding of fundamental epigenetic mechanisms that underlie susceptibility to colon cancer.
Furthermore, the successful completion of this project will provide a mechanistic rationale to pursue combination
epigenetic immunotherapy as a more effective strategy for treating CRC.

Public health relevance
PROJECT NARRATIVE Epigenetic modifications to DNA, such as hypermethylation, play a pivotal role in regulating gene expression during aging and cancer development. By leveraging innovative mouse models and cutting-edge gene editing approaches, we will elucidate age-related epigenetic changes underlying colon cancer pathogenesis and test the effectiveness of combination therapy targeting these changes. Our ultimate goal is to discover novel epigenetic-based strategies for improving outcomes in patients with colon cancer.